TRIAL OF OXCARBAZEPINE IN PATIENTS WITH PARTIAL SEIZURES

This protocol assesses the safety and efficacy of oxcarbazepine monotherapy in epilepsy patients with partial complex seizures whose seizures have been difficult to control with currently available medications.